Neural correlates of in utero HIV and ART exposure: early childhood follow-up of a prospectively recruited cohort

Project Summary
Programs to prevent vertical transmission of HIV have been extremely effective. As a result, there is an
increasing population of HIV-exposed and uninfected children (CHEU). Currently, at least one in every five
children (approximately 4.1 million children) in South Africa is HEU. These children face higher risks even
though they are not infected, exhibiting reduced growth, neurodevelopmental delays and increased risk of
severe infections and even death before age two years. In 2017, we started recruiting a cohort of pregnant
women living with HIV who had either commenced triple-regimen ART prior to conception or during pregnancy
immediately upon testing positive for HIV infection, along with uninfected women. We thus established a cohort
of infants in three study arms viz. unexposed, exposed with ART throughout fetal development, and exposed
with ART started later in pregnancy. In R01 HD085813, we imaged the children at 39-45 weeks equivalent
gestational age with MRI to assess brain development, and we performed cognitive and clinical assessments
at regular intervals. We observed structural, functional and metabolic differences in deep gray and white matter
in CHEU, and poorer cognitive performance at 10 and 20 months. In R01 HD093578, we additionally studied
the relationship between neuroimaging in infancy and between one and two years of age, and microbiome
markers of infant development, including infant nutrition and breastmilk, to establish the relationship between
gut microbial diversity, milk oligosaccharide composition and the brain. This study is ongoing.
There is an urgent need to understand how and why children exposed to HIV are not thriving as well as
their unexposed peers. Early life factors around birth may have consequences throughout life. In this study we
will follow this well-characterized cohort established before birth to examine the effects of pre- and perinatal
HIV/ART exposure on neurodevelopment around ages 6 and 8 years, using multimodality neuroimaging
(morphometry, spectroscopy and connectivity) and clinical and cognitive assessments. This period is important
as the children start school at 7 years. We expect to enroll 150 children from the original infant cohort. Our data
will enable a longitudinal assessment of HIV/ART exposure on neurodevelopmental out-comes, and potential
moderation by environmental factors, infant nutrition and maternal well-being and health.
We will continue to sustain the capacity for pediatric neuroimaging and cognitive assessment built up
over more than a decade of NIH-supported collaboration between Drs. Meintjes (University of Cape Town),
Laughton (Stellenbosch University) and van der Kouwe (Massachusetts General Hospital). We will build new
capacity for brain imaging in resource-limited settings by imaging our cohort with a low-field mobile MRI
scanner alongside the high-field scanner. With these comparative images we will develop longitudinal
morphometric analysis tools to discriminate between healthy and atypical neurodevelopment, making these
algorithms cloud-ready so that they are accessible to users with limited computing resources.

Public health relevance
Project Narrative The success of programs to prevent vertical transmission of HIV has led to a growing population of HIV- exposed, uninfected (HEU) children who, despite not being infected, exhibit neurodevelopmental delays and reduced growth. In this project we will continue to follow a prospectively recruited well-characterized cohort of children without and with HIV exposure, stratified by ART exposure duration, through early childhood with multimodal MR neuroimaging and cognitive assessments around ages 6 and 8 years, examining how factors around birth impact later brain health and how the postnatal environment, including maternal health, influences neurodevelopment and school-readiness. Additionally, we will build capacity for using low-cost mobile MRI scanners to differentiate healthy and atypical neurodevelopment in low-resource settings.